Crosstalk between butyrophilins and gamma delta T cells in human cancer

Differences between mouse and human γδ T cells have hindered a better understanding of the role of these
innate lymphocytes in human cancer, due in part to the lack of relevant transgenic models. Key advances in the
previous funding cycle of this grant underscored the crucial role of γδ T cells in human ovarian cancer and how
butyrophilins govern their phenotypes. Building upon our new preliminary results, our central hypothesis is that
that BTNL9, in a lipid-dependent manner, activates crucial subsets of anti-tumor δ1 T cells in an “innate-like”,
CDR3-independent fashion, through binding to specific variable γ regions. Furthermore, novel allogeneic cellular
therapies using exhaustion-resilient δ1 T cells as a CAR T cell platform, in a BTNL9-dependent manner, will be
more effective at in halting the progression of epithelial human cancers, compared to conventional αβ CAR T
cells, particularly in tumors with low antigenic expression. These hypotheses will be tested in these Aims:
In Specific Aim 1, we will elucidate the detailed mechanism by which BTNL9 activates various subsets of
γδ1 T cells in a lipid-dependent manner. Based on this knowledge, we will also define the crucial role ofBTNL9-
dependent Vδ1 TILs in anti-tumor immunity in human cancer, in conjunction with other γδ T cell subsets.
In Specific Aim 2, we will characterize the heterogeneity and trajectory of evolution of human cancer-
infiltrating γδ1 T cells. These studies will define the anti-tumor activity of different γδ T cell subsets and the
molecular drivers of the evolution of protective phenotypes in vivo in human cancer.
In Specific Aim 3, we will evaluate new allogeneic cell therapies that exploit the resilience of Vδ1 T cell
effector activity in human epithelial cancer. These experiments will provide a rationale for ensuing CAR T cell
therapies using Vδ1 T cells and γδ TCR signals as a potentially superior platform for controlling the progression
of CAR T cell-refractory malignancies, as compared to autologous conventional αβ T cells.
These studies will not only address the knowledge gap concerning the interaction between butyrophilins and γδ
T cells in human cancer, but also establish a mechanistic rationale for novel cellular therapies that can effectively
combat aggressive and common solid human cancers, paving the way for "off the shelf" CAR T cell therapies.

Public health relevance
PROJECT NARRATIVE Despite recent associations with γδ T cell infiltration and better outcome in different human tumors, the immunobiology of this T cell subset, and its potential as a platform for immunotherapies against cancer, remains elusive. The studies proposed in this application have the potential to exert a profound effect in the field of cancer immunotherapy by demonstrating that a subset of γδ T cells, which is more resilient to loss of effector activity at solid tumor beds, is a superior platform for novel Car T cell therapies against tumors that have so far remain stubbornly refractory to cellular therapies. The insight derived from these studies will provide a mechanistic rationale for novel clinical trials, designed to overcome the hitherto insurmountable challenge of controlling epithelial malignancies using cellular therapies, thus advancing towards the cure of one of the most devastating malignancies.